HEALTH SYSTEMS STRENGTHENING TO IMPROVE HEALTH OUTCOMES: APPLYING IMPLEMENTATION

ABSTRACT Despite significant increases in global health investment and the availability of low-cost, efficacious interventions designed to reduce the burden of preventable diseases in low and middle income countries, the translation of these scientific advances into effective delivery strategies has been slow, uneven and incomplete. Health systems play a fundamental role in closing this gap between our scientific knowledge and their delivery at sufficient scale to lead to population-level improvements in health outcomes. However, the complexity of health systems continues to challenge implementation researchers and their efforts to identify and overcome health system barriers, and broadly apply these lessons learned. This goal of this research project, funded through the Doris Duke Charitable Foundation's African Health Initiative, is to improve health outcomes in 13 districts in Sofala province, Mozambique, through strengthened health systems and delivery of integrated primary health care. In specific aim 1, we will assess health systems strengthening interventions including improved data systems, use of data driven decision-making tools, and strengthened leadership and management capacity of district health teams on health system outputs and outcomes. In specific aim 2 we will assess the impact of a package of health systems strengthening interventions including improved data systems, use of data driven decision-making tools, and strengthened leadership and management capacity of district health teams on population-level health outcomes. A quasi-experimental design will be employed to respond to the specific aims, comparing changes in output, outcome and impact measures selected to capture service delivery and health outcome improvements. The results of this implementation research will generate knowledge of global significance to support evidence-based health delivery and health systems planning.

Public health relevance
PROJECT NARRATIVE This research is highly relevant to public health in developing countries, where implementation of health advancements has not reached populations with sufficient speed and scale. Through assessing whether strengthening health systems in Mozambique improves the delivery of health services and the health of populations, we will build evidence on how to design approaches and direct funding in order to maximally improve health at a large scale in developing countries. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In low and middle income countries the translation of health care advancements with established efficacy into effective delivery strategies has been slow and uneven, resulting in significant lost opportunities to reduce illness and death from preventable and treatable diseases. Strengthening health systems has the potential to narrow this implementation gap through increasing access to primary health care services that deliver high quality, effective health services. Global health initiatives have dramatically increased funding for improving the delivery of services targeting priority diseases, as well as broadly strengthening health systems, though there is little evidence on models to guide these health system strengthening efforts. The overall goal of this research project is to improve health outcomes in all 13 districts in Mozambique's Sofala province through strengthened health systems and improved delivery of integrated primary health care. The specific aims of this research will focus on better understanding how one approach to health systems strengthening impacts the delivery of primary health care services and population health status in order to contribute to existing evidence for evidence-based health delivery and health systems planning. Specific Aim 1: To assess the impact of a package of health systems strengthening interventions including improved data systems, use of data driven decision-making tools, and strengthened leadership and management capacity of district health teams on health system outputs and outcomes. Specific Aim 2: To assess the impact of a package of health systems strengthening interventions including improved data systems, use of data driven decision-making tools, and strengthened leadership and management capacity of district health teams on population-level health outcomes. The research described in this proposal is currently underway in collaboration with my mentors and collaborators at the University of Washington and Eduardo Mondlane University, and with involvement of the Mozambique Ministry of Health in Sofala province and researchers at the Beira Operations Research Center (CIOB). The research is significant because it addresses health system barriers to delivering improved health services. Expanding the involvement of interdisciplinary academic researchers to overcoming implementation barriers is also novel, and provides opportunities to develop appropriate research methodologies and analytical techniques in order to better understand complex health systems and test innovations in real world settings.